Advanced Research Training in Communication Sciences and Disorders

PROJECT SUMMARY
This proposed renewal of Boston University's Training Program in Advanced Research Training
in Communication Disorders and Sciences builds on the successful implementation of a multi-
disciplinary, multi-institutional training effort. The current five-year cycle infuses a broad clinical
perspective in trainees, incorporating didactic and research experiences across the full
continuum of effective training in human health (i.e., from investigations of basic and disrupted
mechanisms or communication processes, to treatment research, translation to the clinic, and
broad implementation across health systems). Participating pre- and postdoctoral trainees have
come from programs in Biomedical Engineering, Neuroscience, Psychological & Brain Sciences,
and Speech, Language, & Hearing Sciences. The program is highly competitive at both the pre-
and postdoctoral levels. The impact of this T32 is doubled at the predoctoral level by the
commitment of each participating department to provide identical resources and opportunities
for a “match” Communication Sciences & Disorders trainee for each T32-supported trainee.
The next five-year cycle continues all of these successful components, and adds formal
development for each trainee of a data sciences toolkit. New Key Personnel from Boston
University's recently established Faculty of Computing and Data Sciences (see Biosketches for
Azer Bestavros, Associate Provost for Computing and Data Sciences, and Director of the BU
Data Science Initiative, as well as Eric Kolaczyk, Director of the Hariri Institute for Computing
and Computational Science & Engineering) will provide curricular and research guidance for this
aspect of the program. Required training in data sciences includes demonstrated facility by each
trainee in math, statistics, data wrangling, data mechanics, and machine learning. Coursework
may include data manipulation using Python, data science using R, and image analysis.
The success of our trainees reflects the deep research and training resources of the inter-
disciplinary and cross-institution partnerships comprising this program. Well-established
laboratories guided by experienced and well-funded preceptors, with access to large, diverse
patient populations are supported by experienced leaders and institutional commitment. This
preparation and acculturation of talented trainees contributes substantially to our scientific and
clinical capacity to understand, prevent, and remediate communication disorders.

Public health relevance
PROJECT NARRATIVE Disorders of human communication commonly occur after stroke or head injury, or may appear in early childhood in the form of delayed language development, acquired or congenital hearing impairment, or impaired speech. Reducing the disabling effects of communication disorders on people requires a specialized, highly trained research workforce, relying heavily on a coordinated effort to provide newly emerging scientists with a comprehensive clinical perspective and skillset. The proposed training project is designed to prepare excellent new researchers in the discipline of communication sciences and disorders.